Renewing the heart: cardiomyocyte cell cycle regulation

PROJECT SUMMARY
Heart failure remains a leading cause of morbidity and mortality worldwide. A major issue in the setting of heart
failure is loss of cardiomyocytes, and the inability of adult mammalian cardiomyocytes to replace themselves
by cell cycle re-entry and cell division. In contrast, newts, zebrafish and neonatal mammalian cardiomyocytes
can undergo mitotic cell division to regenerate the heart. Previous studies aimed at provoking cell cycle re-
entry and proliferation of adult mammalian cardiomyocytes have met with partial success. Recalcitrance of
adult cardiomyocytes to efficiently undergo proliferative cell division reflects epigenetic and transcriptional
programs that dictate multiple properties of the adult cardiomyocyte state that provide barriers to their
proliferative ability. These barriers include: activation of cell cycle inhibitors; repression of cell cycle activators;
a metabolic state geared toward availability of relatively high oxygen levels with high numbers of mitochondria,
abundant and highly organized myofibrillar structure, and high levels of binucleation. Thus, alteration of a
signaling pathway or overexpression of a single cell cycle regulator may not be able to efficiently overcome all
these obstacles. Instead, promoting efficient proliferation of adult cardiomyocytes is likely to require a multi-
pronged approach, where each of these obstacles is overcome. Although we know much about epigenetic and
transcriptional programs regulating cardiomyocyte development, our knowledge concerning epigenetic and
transcriptional programs regulating the complex transitions from the fetal to adult cardiomyocyte state
is limited. A comprehensive in depth understanding of these programs will give insight into mechanisms by
which we can overcome multiple barriers within adult cardiomyocytes to promote cell cycle re-entry. In the
proposed studies, we will examine cardiomyocyte cell cycle regulation by a key epigenetic regulator, Dot1L,
identify transcription factor codes driving distinct states of cardiomyocyte cell cycle, examine effects of key
metabolic transcription factors, HIFs, on adult cardiomyocyte proliferation, and investigate the potential role of
atypical E2F factors on cardiomyocyte binucleation and proliferation. Results of these studies will be
groundbreaking and be of future impact in that we hope to provide a roadmap of specific nodal points that
can be targeted to allow the adult cardiomyocyte to undergo productive and regulated proliferation, thus paving
the way for regenerative therapies for the heart.
.

Public health relevance
PROJECT NARRATIVE Heart failure is a leading cause of death in the US and worldwide, and loss of cardiomyocytes is a major contributor to heart failure. Adult cardiomyocytes cannot replenish themselves by proliferation. The overall goals of this study is to develop comprehensive understanding of genetic pathways that dictate the inability of adult cardiomyocytes to proliferate, toward overcoming those barriers to promote cardiomyocyte renewal and preventing heart failure.